DP21-001 Nebraska Pregnancy Risk Assessment Monitoring System

Project Summary
Nebraska Pregnancy Risk Assessment Monitoring System (NE PRAMS) has provided quality
and comprehensive data on maternal and child health risks and behaviors since 1999, and has
become a major participant in the state’s strengthened public health system. PRAMS
complements the vital records database adding nuances that only self-reported data can do.
On the surface, Nebraska appears to have very good pregnancy outcomes. However, the large
percentage (69.6% in 2017-2018) of White births drives state averages, and masks
considerable disparity when outcomes are examined by maternal race and ethnicity. The
Lifespan Health Services Unit is home not only to Maternal and Child Health (MCH)
Epidemiology and NE PRAMS, but also to the rest of the MCH-related programs. These
programs have been among the strongest supporters of PRAMS and users of the data; being
housed in the same unit makes PRAMS data and staff easily accessible to those programs.
PRAMS data has been integrated into the official MCH priorities.
High-quality, Nebraska specific, population-level data are scarce on key factors such as
behavioral risks, and mothers’ experiences with and perceptions of health care. Thus, the birth
certificate registry is limited in its ability to provide detailed information for program planning and
evaluation. NE PRAMS is currently the only readily-accessible source for population-level data
on important issues such as pregnancy intendedness, reasons for patterns of prenatal care use,
nutritional status of the mother, preconception health, and for postnatal behaviors such as
depression, infant sleep position, and breastfeeding. Importantly, PRAMS data allow valid
statements to be made about “new Nebraska mothers” rather than only for selected populations
or program recipients. NE PRAMS stratifies by race/ethnicity and will continue to provide data to
plan strategies to address these issues and for evaluation.

Public health relevance
Project Narrative Nebraska Pregnancy Risk Assessment Monitoring System (NE PRAMS) data is utilized by the Nebraska Department of Health and Human Services (NDHHS) Maternal and Child Health (MCH) programs and other state public health programs as a source of accurate information on state-specific, population-based data on maternal attitudes and experiences before, during, and shortly after pregnancy. NE PRAMS is currently the only readily-accessible source for population-level data on important issues such as pregnancy intendedness, reasons for patterns of prenatal care use, nutritional status of the mother, preconception health, and for postnatal behaviors such as depression, infant sleep position, and breastfeeding. State progra ms, local health departments, and community health organizations across the state that focus on maternal and child health issues have come to rely on PRAMS data to help identify, address, monitor, and evaluate both emerging and previously identified problems.